PHASE II SEROCONVERSION OF SINGLE DOSE AND TWO DOSE MEASLES VACCINATION

Two hundred and seventy patients will be randomized to receive a single measles vaccination (Measles, Mumps, and Rubella Virus Vaccdine Live [MMR- II]) at 12 months of age or receive two measles vaccinations, one at six months (Measles Virus Live [Attenuvax]) and one at 12 months of age (MMR- II). Antibody levels will be measured to evaluate patient response.